CTSA Postdoctoral T32 at the University of Texas Health Science Center at Houston

PROJECT SUMMARY/ABSTRACT
Programs designed to train future generations of researchers who are able to think and work together in
cross-disciplinary, team environments are central to the advancement of translational science in the United
States. With the accelerating pace of discovery in biomedical science the need for translational scientists is
greater than ever. The goal of this postdoctoral T32 application is to provide high-level, effective training to
translational science researchers at the postdoctoral level who will build a community of clinical and translational
scientists by leveraging the multi-institutional, multi-disciplinary strengths of a Center for Clinical and
Translational Sciences (CCTS) Clinical and Translational Science Award (CTSA) based at the University of
Texas Health Science Center at Houston (UTH-H). Through the TL1 Training Core which preceded this
application, which was awarded as part of the CCTS CTSA, we already have a successful record of training a
diverse and productive group of translational scientists.
Historically, postdoctoral trainees supported by the TL1 Training Core have been employed at two major
institutions within the Texas Medical Center (TMC), UTH-H and the MD Anderson Cancer Center (MDACC).
However, a unique aspect of our CCTS is the inclusion of partner institutions spanning the state of Texas. In this
T32 proposal, we will continue to train leaders in translation science while integrating trainees from all CCTS
partner institutions. This will bring additional diversity to the T32 since these trainees will draw upon the broad
racial, ethnic, gender, economic, and social backgrounds represented in Texas, which is thought to be a blueprint
for the nation's future demographics. Furthermore, the training faculty and their mentees at the CCTS partner
sites will bring awareness of unique research topics and collaborative opportunities to the forefront of the T32
trainee experience for those based in the TMC. The following aims will enable us to achieve our application
goals: Aim 1. Attract and retain postdoctoral trainees with potential to develop into leaders in translational
science; Aim 2. Leverage the strengths of the unique Center for Clinical and Translational Sciences ecosystem
to train postdoctoral fellows in principles of translational science; Aim 3. Enhance diversity among postdoctoral
trainees in translational science.
We will achieve these aims by leveraging the world-class educational and research opportunities within the
TMC to train translational scientists across the state. By drawing upon the trainee diversity that is available in
our partner institutions that train postdoctoral fellows (Rice University, UT-RGV, UT-Tyler, and TT-EP), this
postdoctoral training program is uniquely positioned to create the translational science leaders of the future. We
anticipate this training will fill the need for creating a wide-ranging pool of translational scientists who are diverse,
innovative, productive, and capable of addressing the health needs of a wide-ranging populace through research.

Public health relevance
PROJECT NARRATIVE This postdoctoral T32 application is designed to train 3 translational science researchers at the postdoctoral level who will help build a community of clinical and translational scientists by leveraging the multi-institutional multi-disciplinary strengths of a Center for Clinical and Translational Sciences (CCTS) Clinical and Translational Science Award (CTSA) based at the University of Texas Health Science Center at Houston (UTH-H). Through the TL1 Training Core which preceded this application and was awarded as an educational arm of the CCTS CTSA, we have already successfully trained postdoctoral fellows who have gone onto productive jobs within the translational science spectrum. In this proposal, we will continue to train future leaders in translation science while integrating trainees from CCTS partner institutions across Texas, which will bring additional diversity to the T32 since these trainees draw upon the broad racial, ethnic, gender, economic and social backgrounds represented in Texas, and will enable the sharing of unique ideas and collaborative opportunities among our CCTS partners.